Mechanisms and Role of Spontaneous Retinal Waves in Visual Development.

PROJECT SUMMARY
Experiments in this proposal will advance our understanding of mechanisms responsible for the development of
precise neural circuitry in the mammalian brain. Patterned activity is critical for normal development of neural
circuits, and deficits in activity-dependent circuit refinement are associated with neurodevelopmental disorders
such as Fragile X syndrome, autism, and amblyopia. Amblyopia is the most common cause of monocular visual
impairment among young and middle-aged adults, with approximately 3 in 100 children effected. Amblyopia is
characterized by a range of deficits in spatial vision, spatial contrast sensitivity, and other tasks. However, the
mechanisms of this maladaptation are not well understood. We will employ a broad range of techniques,
including molecular biological, cell biological, neuroanatomical, electrophysiological and advanced optical
imaging techniques in vitro and in vivo. We focus our experiments on neural circuits in the midbrain superior
colliculus and visual cortex of the mouse. Beyond the retina, these areas are the largest visual structures in the
brain. The superior colliculus is a sensory motor structure that has emerged as an ideal model system for the
examination of neural circuit development and function. The visual cortex is a canonical model system for the
study of higher order brain function and development in mammals. It is widely hypothesized that molecular cues
are responsible for the establishment of gross brain circuit features, and activity dependent processes
subsequently refine these circuits to functional precision. The emergence of visual circuit features before the
onset of sensory experience suggests that visual map formation is first initiated by activity-independent
mechanisms, such as axon guidance molecules, then refined by pre-vision correlated spontaneous activity, and
later maintained and sharpened by visual experience after eye-opening. Spontaneous bursting of retinal ganglion
cells results in propagating waves of activity that change with age based on their primary excitatory drive. Initially
characterized in vitro, stage I waves occur before birth and are mediated by gap junctions between retinal
ganglion cells. Stage II occur from birth until around P10 and are mediated by cholinergic starburst amacrine
cells. Stage III waves are glutamatergic in origin, with bipolar cells providing the primary excitatory drive onto
retinal ganglion cells from P10 until eye-opening. This project aims to examine the specific spatiotemporal
features and the underlying cellular mechanisms by which retinal waves are instructive for the development of
higher order circuits and neuronal response properties, in both subcortical and cortical circuits, prior to eye
opening.

Public health relevance
PROJECT NARRATIVE We are interested in understanding how complex brain circuits develop. We focus on the visual system, as its function is relatively well understood and it is especially important to human behavior. Our experiments have the potential to help develop techniques to restore visual function following eye trauma or disease, such as glaucoma, age related macular degeneration or amblyopia.